2022 Microbial Stress Response GRC/GRS

Project Summary
Bacteria and Archaea face a nearly constant onslaught of diverse stressors, including nutrient limitations,
temperature changes, antibiotics, phage, host immune systems, and more. Whether they can properly detect
and respond to such stressors largely determines their survival in a world of fierce competition. Microbes have
evolved finely tuned and sophisticated regulatory mechanisms for responding to stress by controlling genome
duplication and repair, gene expression, proteostasis, RNA processing, and both central and secondary
metabolism - collectively, these responses enable survival in a range of harsh conditions. Thus, delineating
how microbes respond to stress will elucidate the fundamental principles governing key cellular processes that
are conserved from bacteria to humans where they prevent genetic disease and cancer. Understanding how
microbes respond to stress impacts areas such as biotechnology, ecology, environmental biology,
geochemical cycles, as well as the symbiosis and pathogenesis relationships that microbes establish with their
eukaryotic hosts.
The latest advances in this field will be the subject of the 2022 Gordon Research Conference (GRC) on
Microbial Stress Response to be held July 17-22nd at Mount Holyoke College. This meeting will bring together
a demographically diverse group of 200 international scientists seeking to understand how microbes sense and
respond to challenging and ever-changing environments. Attendees are encouraged to present posters of their
most exciting research. Emphasis will be placed on new approaches to understanding interactions between
microbes and the environment, particularly modern imaging, genetic, metagenomic, and computational
strategies for the analysis of bacterial physiology and community structures under conditions of stress and
competition.
A key feature of this conference is its welcoming and highly interactive environment that brings together
investigators at all levels. Invited speakers include established and highly recognized scientists as well as
junior investigators. Approximately 50% of invited speakers are women and 40% of oral presentations will be
selected from the submitted abstracts with an emphasis on those by new investigators, postdoctoral scientists,
and graduate students. Postdoctoral and graduate student participation is further encouraged by the
accompanying Gordon Research Seminar (GRS), organized by students, trainees, and early stage
investigators for their peers. We anticipate the 2020 Microbial Stress Response GRC will continue the success
of its predecessors with cutting edge discoveries unveiled for the first time to a multidisciplinary and critical
audience.

Public health relevance
Project Narrative This proposal seeks funding for a multidisciplinary conference on a topic – microbial stress response – that explores human health fundamental topics. These topics include investigations of antibiotic resistance and microbial pathogenesis, beneficial microbe-host interactions, and microbial metabolism that shapes terrestrial environments.